Phage-mediated horizontal gene transfer in Borrelia burgdorferi

PROJECT SUMMARY/ABSTRACT
Lyme disease is caused by infection with the spirochete Borrelia (Borreliella) burgdorferi. These spirochetes
are themselves infected by the phage ϕBB-1. Phages are viruses that infect bacteria and are the most
ubiquitous biological entities on the planet. ϕBB-1 is a temperate phage, which has two types of replication: the
lytic cycle involves assembly of phage particles followed by release outside of the bacterium and lysogenic
cycle involves incorporation of the phage into the bacterial genome. The ϕBB-1 prophage are the cp32s, a
large group of nearly identical 32-kb circular plasmids universally found in every species of Borrelia. The
central hypothesis of this application is that ϕBB-1 phage drive horizontal gene transfer of antigens between B.
burgdorferi strains and that this process maintains the spirochete in its reservoir host, allowing for reinfection of
individuals. There have been very few studies on the biology of ϕBB-1 and its role in transduction, the
movement of genetic material between individual B. burgdorferi spirochetes by the ϕBB-1 phage. We endeavor
to uncover the mechanism regulating ϕBB-1 replication and the effect of transduction on the ability of B.
burgdorferi to cycle between its tick vector and vertebrate host. The following specific aims are proposed to
accomplish these research goals: 1) Measure horizontal gene transfer between heterologous Bb strains in the
tick vector; 2) Define the role of ϕBB-1 in maintaining spirochete infectivity in previously infected mice; and 3)
dissect the mechanism of the ϕBB-1 lysis/lysogeny decision. Genetic, genomic, biochemical, and
transcriptomic approaches, as well as the tick-mouse model of Lyme disease, will be utilized to experimentally
pursue these aims. In this innovative application, the team of PIs have generated compelling preliminary data
and are in the unique position of having the experience, expertise, and experimental models to enhance the
mechanistic understanding of ϕBB-1 biology, including the regulation of replication decisions and the
consequences of transduction on the ability of B. burgdorferi to infect previously infected hosts. The long-term
objective of this proposal is to understand the role of ϕBB-1 phage on B. burgdorferi microbiology and Lyme
disease pathogenesis, which will lead to improved diagnostic, prevention, and treatment strategies because
genetic diversity is required for the maintenance of B. burgdorferi in its tick-vertebrate cycle as well as for the
reinfection of previous Lyme disease patients; this is relevant to the mission of the agency to “seek
fundamental knowledge” for the sake of alleviating human disease.

Public health relevance
PROJECT NARRATIVE Lyme disease is the most common vector-borne infection in the United States, with nearly 500,000 cases per year. The bacterium Borrelia (Borreliella) burgdorferi causes Lyme disease when it is transmitted to humans by a tick vector. Bacteria, including B. burgdorferi, can themselves be infected by bacteriophages (phages), a type of virus. This application proposes to fill a knowledge gap regarding the fundamental understanding of B. burgdorferi phage biology, including the molecular basis of phage replication and the mechanisms by which phage facilitate movement of genes between bacteria, enhancing the persistence of B. burgdorferi in nature via reinfection of its hosts.